PHASE I TRIAL OF PIROXANTRONE IN PATIENTS WITH ADVANCED CANCER

Piroxantrone, and anthrapyrazole currently in Phase II testing, was of interest due to its potential for combining an anthracycline's broad antitumor efficacy with a lower risk of cardiotoxicity.